Microbial regulation of the keratinocyte AHR

PROJECT SUMMARY
The complexity of microbial communities inhabiting the healthy human skin have been illuminated in recent
years, as well as signatures associated with inflammatory skin diseases such as atopic dermatitis. However,
the molecular and biochemical mechanisms that mediate microbial symbiosis with the skin are not well
understood. We recently found that homeostatic skin barrier function, epidermal differentiation, and recovery
from injury are dependent on the microbiota in mice. These effects were mediated by the keratinocyte aryl
hydrocarbon receptor (AHR). The AHR is a ligand-dependent xenobiotic receptor of foreign/toxic substances
that is also known to regulate epidermal differentiation, tight junction/adhesion, and antimicrobial innate
immune responses. The objective of this project is to identify and characterize microbial ligands of the AHR,
and to test their utility in treating skin barrier dysfunction and infection. Epidermal barrier dysfunction is a key
feature of atopic dermatitis, a common skin disorder characterized by chronic and relapsing, itchy, inflamed,
skin lesions and dysbiotic microbiota. To test the hypothesis that commensal bacteria mediate AHR signaling
to promote skin barrier integrity and defense, we propose three aims. 1) Define microbial mechanisms of
keratinocyte AHR regulation that promote barrier repair; 2) Establish pharmacodynamic actions of microbial
AHR ligands to promote skin barrier function and antimicrobial defense; and 3) Evaluate microbial AHR ligands
in treatment of epidermal barrier dysfunction and S. aureus infection in murine models. Findings from these
studies will provide novel, accessible targets to promote skin barrier function and repair, while advancing
fundamental understanding of cutaneous host-microbiota interactions.

Public health relevance
PROJECT NARRATIVE The skin is colonized by microbial communities, but their role in the barrier function of the skin is not well- defined. The proposed research will illuminate the molecules produced by beneficial skin microbes, their impact on the skin, and their therapeutic potential for treating inflammatory and infectious skin diseases. Findings from these studies will provide insight into fundamental roles of our endogenous microbiota while advancing targets for the treatment of skin disease.